NORMAL RANGE FOR RED BLOOD CELL FOLATES

We hypothesize that current measurements of red blood cell folates are inaccurate and therefore underestimate the true incidence of folate deficiency. We seek to establish a normal range for total red blood cell folates using a new gas chromatography/mass spectrometry method and to establish the prevalence of subclinical folate deficiency in a cohort of apparently normal population.